Multidisciplinary Training in Critical Care Outcomes Research

PROJECT SUMMARY
In this application we propose to continue our highly successful multidisciplinary post-doctoral training
program in critical care outcomes research. The training program provides 2-3 years of research
training in the areas of critical illness and acute organ dysfunction, with a focus on complex critical
illness syndromes such as acute lung injury and sepsis. The academic home of our training program
is the CRISMA Center, an interdisciplinary research center with over 30 extramurally funded faculty
members, 40 research staff members, and multiple core facilities for administrative support, laboratory
work, and data management. CRISMA post-doctoral scholars will train in one of five interrelated areas
based on CRISMA’s five scientific programs: (a) immunobiology and the cellular basis for organ injury;
(b) systems modelling and computational biology; (c) clinical epidemiology of critical illness; (d) critical
care ethics and decision making; and (e) critical care organization and management. In this renewal
application we have further strengthened our training program by expanding training opportunities in
precision medicine, predictive analytics, implementation science, and decision science. Trainees
partner with their principle trainer and their training group to develop structured, written career
development plans. Training activities include intensive mentorship in the form of weekly meetings
with primary mentors and monthly meetings with their mentorship teams; didactic education in the
form of formal coursework in research methodology through the University of Pittsburgh Institute for
Clinical Research Education, in most cases culminating in the attainment of a master’s degree; and
experiential research in which trainees design, execute, and complete mentored research projects in
their chosen area of study. In addition, trainees present and receive feedback on their ongoing work
through participation in weekly research seminars; as well as receive interactive instruction in the
responsible conduct of research in both formal and informal settings. The training environment is
supported by numerous training and career development resources at the University of Pittsburgh,
including tight integration with our University’s Clinical and Translational Research Institute. Overall,
our training program is designed to create an innovative scientific workforce with the skills necessary
to answer the most pressing research questions in the field of critical illness and acute
cardiopulmonary disease.

Public health relevance
PUBLIC HEALTH RELEVANCE Over 4 million Americans are admitted to an intensive care unit each year, and mortality for critical illness syndromes such as acute lung injury and sepsis exceeds 25%. This training program will provide post-doctoral scholars with state-of-the-art, interdisciplinary training in critical care outcomes research spanning T2, T3, and T4 translation, creating a scientific workforce with the skills, experience, and training to design and execute research studies that will improve patient-centered outcomes for patients with critical illness and acute cardiopulmonary disease.